GeneRAlizable Sepsis Phenotyping (GRASP) using Electronic Health Records and Continuous Monitoring Sensors

Abstract
Sepsis, a heterogeneous syndrome characterized by whole-body inflammation caused by the body's
response to an infection, is the most expensive and deadly condition treated in hospitals, with over 270,000
cases of sepsis-related deaths in the U.S. alone. Untreated sepsis may result in dilated and leaky blood
vessels and severe hypotension requiring vasoactive medications (aka septic shock), and eventual injury to
kidneys, lungs, and liver (aka organ injury) with mortality rates in excess of 40%. Successful prevention and
management of sepsis, septic shock, and organ injury rely on the ability of clinicians to anticipate and
estimate the risk, and administer the right life-saving treatments (e.g., antibiotics, fluids and vasopressors)
at the right time. In recent years, data-driven modeling has been shown to enable early prediction of sepsis
and to reveal clusters (or phenotypes) of sepsis, which may help with personalizing therapeutic
interventions. However, crossing the translational chasm between clinical research and improving patient
care also requires addressing 1) `data deserts' at different levels of care through better data integration,
smarter lab ordering, and utilization of continuous monitoring wearable sensors; 2) interoperability and
portability of clinical data and analytics; 3) principled dissemination and implementation studies; and 4)
education of the next generation of caregivers to effectively utilize advanced analytical tools.
The proposed research program builds upon PI's K01 early career development award focused on
multicenter development and validation of sepsis predictive analytic algorithms (including hourly EHR data
spanning ED and inpatient encounters from over 500,000 hospitalized patients across five district
healthcare systems). Drawing insights from recent advances in domain adaptation and multi-task learning
(sub-fields of machine learning), this project aims to discover generalizable dynamic phenotypes that are
directly relevant to the prediction and management of sepsis, septic shock, and downstream organ injury.
We propose to augment EHR-based analytics with high-resolution data from bedside devices (e.g.,
monitors, ventilators, dialysis, and IV pumps) and wearables (e.g., continuous blood pressure and lactate
sensors) to address existing gaps in monitoring. Additionally, this program aims at advancing FHIR (Fast
Healthcare Interoperability Resources) and OMOP (Observational Medical Outcomes Partnership)
interoperability standards through the implementation of specific resources for high-resolution data sources.
Finally, this research program will be conducted in close collaboration with our dissemination and
implementation and hospital quality improvement teams to ensure early assessment of usability, barriers to
implementation, and effective education to maximize the potential for clinical impact.

Public health relevance
Project Narrative The proposed project is making use of Internet of Things (IoT) sensors and computers to collect and analyze data from hospitalized patients with sepsis. We plan to develop methods to identify patterns in the patient data which predict who is at risk for deterioration and which treatments they may benefit. We have a very strong team of doctors and researchers who work closely together, covering all aspects of the proposed research, which we hope will help us improve the care of hospitalized patients with sepsis.